B cell responses in heparin-induced thrombocytopenia

ABSTRACT
Heparin-induced thrombocytopenia (HIT) is the most common drug-induced immune thrombocytopenia and can
lead to catastrophic thrombosis in an affected patient. Antibodies that recognize the platelet alpha-granule
protein, platelet factor 4 (PF4), in a complex with heparin are central to HIT pathogenesis. Human B cells have
extensive heterogeneity. Innate-like B cells, such as B1 and marginal zone (MZ) B cells, later germinal center
(GC) B cells, different types of memory B cells, and extrafollicular plasmablasts all play an importance and unique
role in the development of humoral immunity. Rapid onset of HIT antibody production and apparent lack of
immunologic memory suggest T-cell independence whereas IgG antibodies typical of HIT argue for T cell
involvement. The profound heterogeneity of human B cells and the ambiguous features of the HIT antibody
response have confounded efforts to identify the pathogenic B cells and characterize the atypical immune
response in HIT patients. In a mouse model, we have demonstrated that MZ B cells play a critical role in HIT
antibody production. In the immediate past grant period, we discovered that in mice, breakdown of immunologic
tolerance was involved in HIT antibody production and T helper cells and regulatory T cells could mediate the
production of PF4/heparin-specific HIT antibodies. We also identified several novel pathways controlling B cell
tolerance that was critical for controlling production of autoantibodies. Importantly, from HIT human patients, we
cloned PF4/heparin-specific and platelet-activating antibodies possessing a unique RKH- or Y5-motif in the
heavy chain complementarity determining region 3 (HCDR3) region that contributes the most to affinity and
specificity of antigen binding. We found that a higher percentage of PF4/heparin-specific B cells, compared to
the control B cells, exhibited extrafollicular B-cell features and an atypical memory B cell (atyMB) phenotype.
Based on these findings, we hypothesize that PF4/heparin-specific B cells undergo extrafollicular response to
follow a distinct differentiation path from activated naïve B cells first into atyMBs and then into plasmablasts in
HIT patients. To test this hypothesis, we will (1) study the characteristics of PF4/heparin-specific B cells in HIT
patients through integrative analysis of phenotypical, transcriptional and epigenetic responses of these B cells
and (2) investigate the origin and developmental trajectory of PF4/heparin-specific B cells that produce platelet-
activating antibodies in HIT patients. The proposed studies will identify the key features of PF4/heparin-specific
B cells and their correlation with disease progression and severity and will discover the evolution of PF4/heparin-
specific B-cell response. Completion of the proposed studies will provide novel insights into the molecular
pathogenesis of HIT and guide future diagnosis, prevention and treatment of this potentially devastating disease.

Public health relevance
Project Narrative Heparin-induced thrombocytopenia (HIT) is the most common drug-induced disorder and can lead to catastrophic thrombosis in an affected patient. The proposed studies aim to identify and characterize the disease-causing B cells in the patients and may help to identify novel therapies for this potentially devastating disease.